BASIS OF SUBSTRATE SELECTION BY BACTERIAL ADAPTOR PROTEINS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The main focus of this project is the determination of the mechanism behind substrate selection by adaptor proteins and the elucidation of the mechanism behind substrate transfer from adaptor proteins to bacterial proteases.